Developing and Applying Analytical Models of Influenza Transmission

Our current scientific knowledge indicates the importance of influenza transmission via exhaled viral bioaerosols
over short and long ranges in indoor environments. The turbulent nature of indoor airflows coupled with the
dynamic nature of exhaled bioaerosol sources and the poor understanding of fundamental source terms
(including distribution of infective virus by aerosol size and number of viral particles per aerosol) creates
difficulties in predicting and tracking aerosol-driven transmission. To address this challenge, novel sampling,
collection, and infective virus assay technologies developed in the Advanced Bioaerosol Technology Core
(ABTC) will allow the Clinical and Biostatistics Core (CBC) and Research Project 1 (RP1) to design and
implement a cohort study capable of collecting critical data sets from both the cohort human subject exhaled
breath and the controlled environment of the clinical facility where the cohort study will take place. Based on
these critical datasets, Research Project 2 (RP2) will develop both well-mixed and high-fidelity analytical models
for deployment in other cohort studies and physical tracking of viral bioaerosol from cohort donors to the
recipients. This direct physical bioaerosol link is important to track actual exposure of recipients to viral
bioaerosols based on both data and high -fidelity models. Furthermore, this link will enable translation of both
cohort data and high-fidelity model results into well-mixed analytical models capable of accounting of quanta
(dose) for modeling of risk of influenza transmission. A careful design of the cohort study experiment setup in
the clinical facility is the first aim in this RP2 project (Aim 1). The setup design will include on-site data collection
on ventilation rates and installation of environmental controls with UV air disinfection. Furthermore,
Computational Fluid Dynamics (CFD) models will allow to define a face shield shape that will block sprayborne
exposure with minimal impact on aerosols. The cohort study in RP1 will use both the identified face shield shape
and the environmental controls for the interventions. The data from the intervention cohort studies will support
the second aim in RP2 focused on analytical modeling of aerosol-driven transmission of influenza (Aim 2). In
this most important aim of RP2, we will characterize the quanta (dose) that resulted in recipient cases of
influenza, allowing us to link the dose to both bioaerosol shedding rate from exhaled breath measurements and
environment aerosol fate. The aerosol concentration and ultimately aerosol fate will be available through
validated high-fidelity modeling of temporal and spatial distributions of bioaerosols. A rigorous validation process
of our high-fidelity models will use both continuously monitored environmental data (CO2, temperature, humidity)
and viral bioaerosol data. These unique data sets will allow the team to create different type of influenza
transmission models to distinguish between the short and long range bioaerosols. The final step is to extend our
analytical models to other environments such as household cohort and ferret influenza studies. RP2 will provide
both analytical models and a web-based tool for user-friendly access in the field.